STABLE RENAL TRANSPLANT PATIENTS CONVERTED FROM SANDIMMUNE TO NEORAL

Cyclosporine A is an established form of immunosuppressive treatment in organ transplantation involving kidney, liver, or heart. The absorption of cyclosporine during chronic administration of Sandimmune soft gelatin capsules and oral solution is known to be highly variable. It is recommended that patients taking the soft gelatin capsules or oral solution over a period of time be monitored at repeated intervals for cyclosporin A blood levels and subsequent dose adjustments be made in order to avoid either toxicity due to high levels or posible organ rejection due to low levels of cyclosporine A. Neoral is a new form of Sandimmune which utilizes a microemulsion technique that facilitates the absorption of cyclosporin A. In healthy normal volunteers, administration of Neoral soft gelatin capsules has demonstrated consistent and improved absorption characteristics resulting in a more predictable pharmacokinetic profile relative to Sandimmune soft gelatin capsules. It is hypothesized that this new microemulsion formulation of Sandimmune, because of its more consistent and improved absorption characteristics, will facilitate the management of transplant patients.